The Chromatin Remodeling Factor ARID1a and the Epigenetic Landscape In Pulmonary Arterial Hypertension

PROJECT SUMMARY
Pulmonary arterial hypertension (PAH is a rare, progressive, incurable, and fatal cardiopulmonary vascular
disease leading to right ventricle failure and ultimately to death. Despite the available treatments and ongoing
research efforts, there is currently no curative treatment against PAH or pathological vascular remodeling.
Changes in chromatin that can influence the epigenetic regulation of many genes and their functional
consequences on vascular remodeling in PAH are poorly understood. The SWItch/Sucrose Non-Fermentable
(SWI/SNF) chromatin remodeling complexes control the accessibility of chromatin to transcriptional and
coregulatory machinery. The AT-rich interactive domain-containing protein 1a (ARID1a), a subunit of the
SWI/SNF chromatin-remodeling complex, plays key roles in normal physiology and diseases. The functional
implications of ARID1a deficiency are dependent on its downstream transcriptional consequences, which can
be altered by other epigenetic transcriptional regulators in the specific cellular context. Homeostasis requires
balanced action of ARID1a and the Enhancer of Zeste Homolog2 (EZH2), a histone methyltransferase, through
chromatin-mediated gene expression. Yet, the role of ARID1a in PAH remains understudied. Given the various
studies implicating ARID1a as a critical tumor suppressor, the objective of this proposal is to investigate the
expression level of ARID1a and the link between ARID1A and EZH2 in pulmonary vascular smooth muscle cells
(PASMCs) growth and dysfunction. The central hypothesis is that ARID1a loss impairs enhancer-mediated
gene regulation and drives aberrant growth of PASMCs in PAH through altered chromatin accessibility and/or
DNA methylation via EZH2. The hypothesis is supported by preliminary data of a significant reduction of ARID1a
expression level in PAH human and animal models of PAH. Importantly, ARID1a depletion increases PASMC
proliferation and increases EZH2 expression. Hence, the hypothesis will be tested by pursuing the following
three specific aims: 1) Investigate the function of ARID1A in PASMC phenotype, and the central role of ARID1a
in the chromatin dynamics and the regulation of gene expression in PASMCs; 2) Evaluate the impact of SMC
conditional ARID1a ablation in the pathogenesis of PAH; and 3) Assess the effectiveness of the combination
therapy of AAV2.5/ARID1a with EZH2 inhibitors in the context of severe rat models of PAH. The data generated
from this proposal will advance our knowledge about the role of ARID1a in the phenotype of PASMC-driven
pulmonary vascular disease with implications for potential therapeutic interventions in PAH.

Public health relevance
Project Narrative This proposal is relevant to public health for understanding the link between the epigenetic modifications and chromatin-remodeling that control many genes that are aberrantly expressed or turned off in the lung vascular cells in pulmonary arterial hypertension (PAH). This project will also carry out the feasibility studies evaluating the combination therapy using gene therapy and small compounds as therapeutic strategies to address the unmet need for effect therapies that target lung vascular cells dysfunction in PAH disease.